PASSIVE MRI CARDIOVASCULAR GUIDEWIRE - SBIR TOPIC 81-PHASE IPERIOD OF PERFORMANCE: AUGUST 1, 2014 THROUGH JULY 31, 2015 PP 8/1/14-7/31/15

The Contractor shall develop an exchange-length guidewire that is safe for operation during MRI. As part of the Phase I award, the Contractor shall develop and test a guidewire prototype.